Deciphering How Bacterial Surface Properties Influence Social Behaviors

Project Summary
Cystic fibrosis (CF) is a genetic disease that results in persistent and chronic lung infections which reduce
lung function over time. Pseudomonas aeruginosa (Pa), an opportunistic bacterial pathogen that infects
patient’s lungs at a young age and persists throughout life, is a major contributing factor. Why antibiotic
treatments against Pa ultimately fail remains unclear, but one plausible explanation is that the organism
resides in spatially organized aggregates within the CF lung, where cells adapt to the host environment and
evade immune responses and resist therapeutic interventions. It was recently shown that environmental
factors such as host derived polymers (e.g. mucin & eDNA) influence the organization of bacterial
aggregates, while changes in lipopolysaccharide (LPS) O-specific antigen (OSA) structure drives the
formation of different aggregate-types and limit the physical impact of polymers due to alterations in cell
surface hydrophobicity. This suggests a crucial interplay between cell surface properties and the physical
features of the environment, which potentially sheds new light on the role of OSA in CF lungs in helping to
enhance or reduce cooperative and competitive interactions between cells. This study will therefore focus on
understanding how changes in LPS composition influences aggregate-type and cooperative interactions in
heterogenous populations of Pa sourced from CF lungs. The main goals are to (i) determine the changes in
frequency of Pa isolates with differential OSA structure in CF airways; (ii) investigate the role of LPS on cell
surface hydrophobicity, aggregate assembly type and spatial organization of Pa populations; (iii) assess how
aggregate-type and alginate production influence tolerance to antibiotics and (iv) evaluate the impact of
spatial organization on social dynamics in Pa populations. The research described in this project will provide
valuable insights into how the hydrophobicity of the bacterial cell surface which is dictated by the LPS-type,
influences aggregate formation and social interactions. A deeper understanding of this will help inform as to
how and why Pa variants co-exist in chronic infections and why social behaviors are maintained or lost. In the
future, these ideas and findings can be extended to other social traits and microbiome studies involving
multiple species.

Public health relevance
Project Narrative Microbial cooperative and competition interactions are common, and in pathogenic organisms, often important drivers of biofilm formation and antimicrobial resistance. In the airways of cystic fibrosis patients, Pseudomonas aeruginosa cells frequently grow in freely suspended aggregates, however, the mechanisms that govern the shape and size of bacterial aggregates during infection are not well defined. This project will provide greater understanding of the interplay between physical environmental constraints imposed by polymers, properties of the bacterial cell surface and how these factors impact on aggregate formation, antimicrobial tolerance and quorum sensing-dependent cell-to-cell interactions.